A machine learning ultrasound beamformer based on realistic wave physics for high body mass index imaging

PROJECT SUMMARY
Obesity is a significant and growing problem in the United States. Currently, 68.5% of the U.S. population is
overweight, with approximately 37.7% of the overweight population being obese. The significant health problems
associated with overweightedness and obesity, the “body habitus” of this population combined with the significant
challenges in medical imaging of these individuals reduces the effectiveness of healthcare for this population. In
ultrasound imaging, the quality of abdominal ultrasound exams are significantly affected by obesity.
Fundamentally, an ultrasound image relies on acoustic propagation to a target, reflection, and then
propagation back to the surface. The process of beamforming, which converts the surface measurement to an
image, is sensitive to the low amplitude reflections from different tissue layers and tissue properties. Typically,
the additional fat and connective tissue layers in obese patients can significantly degrade ultrasound image
quality by introducing multi-path reverberation and phase aberration that obscure or distort these low amplitude
reflections.
However, due to the computational complexity of describing ultrasound propagation and reflection in
heterogeneous media, beamformers currently rely on simplified models that do not describe the propagation
physics directly. We propose a generational leap in how we approach ultrasound beamforming by using
physically and anatomically realistic wave propagation models and measurements that can effectively harness
the power of data-driven and rapidly evolving machine learning beamformers. A custom highly realistic simulation
tool that we have developed will use acoustical maps of the fine structures in the human body based on
photographic cryosections. This physics-based approach will allow us to develop high quality training data and
to understand the physical mechanisms for image quality improvement. These simulations will be calibrated to
ex vivo and in vivo human data to subsequently generate a large data set that can be used to train a machine-
learning-based real-time beamformer. We will focus on two sources of image degradation which we have
identified to be particularly deleterious: multipath reverberation and aberration of the focusing profile. The
proposed neural network beamformer filters incoherent noise, such as multi-path reverberation, and corrects
aberration in the radiofrequency channel signals.
After training the beamformer and implementing it in real-time, a pilot human study in liver ultrasound imaging
will be conducted to determine the improvement in image quality in high-body-mass index individuals, where
diagnostic imaging is problematic due to image degradation. This technique is highly translatable to other clinical
scenarios, varying from cardiac to transcranial to obstetric imaging, by changing the anatomical model.
Furthermore, the physical concepts that will be extracted from the learned representation, can be used to improve
the design process for ultrasound equipment, including transmit sequences, and transducers.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Ultrasound beamforming, the process of transforming ultrasound into an image, is based on the principles of wave propagation which are complex due to the soft tissue structure in the human anatomy. Currently, ultrasound imaging uses simplified models of wave propagation. Here we address these limitations with physically and anatomically realistic propagation models based on the human anatomy that can effectively train and harness the power of machine learning beamformers. This technique directly addresses the principal challenge and objective of ultrasound beamforming, which is to limit unwanted acoustical effects from superficial tissue while maximizing signal from deep targets. The advancement of the proposed technology addresses the clear clinical need to provide diagnostic imaging to the growing population of body-limited imaging cases.